CD45 mediated regulation of PMN function during intestinal inflammation

Abstract:
It has been well documented that disease activity in inflammatory mucosal diseases including inflammatory
bowel disease is linked to the transepithelial migration of neutrophils through the mucosal epithelium and
ultimately into the intestinal lumen. Co-incident with massive luminal influx of neutrophils is uncontrolled release
of toxic tissue damaging metabolites that contribute to mucosal and/or transmural injury including edema, loss
of goblet cells, decreased mucus production, crypt cell hyperplasia, ulceration and crypt abscess formation. The
complex signaling mechanisms that regulate neutrophil transepithelial migration and inflammatory function in
mucosal tissues have not been fully elucidated even though excessive neutrophil activation is heavily implicated
in disease pathology of IBD and other inflammatory disorders. Preliminary data identifies the tyrosine
phosphatase CD45 as an important regulator of neutrophil intestinal infiltration and inflammatory function. This
proposal will determine effects of neutrophil specific loss of CD45 on intestinal inflammation and repair using
novel neutrophil specific CD45 deficient mice. We will also determine how CD45 phosphatase activity regulates
neutrophil intracellular signaling pathways and inflammatory effector functions including migration,
degranulation, and superoxide release. Finally using specific antibodies and glycan binding proteins we will
determine how specific CD45 isoforms and glycoforms can be targeted to regulate neutrophil activation and
inflammatory responses. Elucidating beneficial effects of targeting neutrophil CD45 phosphatase activity during
colitis will help to develop novel strategies to ameliorate pathological intestinal inflammation.

Public health relevance
PROJECT NARRATIVE Dysregulated mucosal trafficking and activation of neutrophils in the intestine are major factors contributing to pathobiology of inflammatory bowel disease (IBD). The goal of this application is to determine how neutrophil CD45 can be selectively targeted to down regulate excessive neutrophil migration and effector functions during intestinal inflammation. Results from these studies will provide ideas for new cell targeted therapies to reduce pathological inflammation and improve quality of life for individuals with IBD and other mucosal inflammatory disorders.